2025 Cornea and Ocular Surface Biology, Pathology and Regeneration Gordon Research Conference

Project Summary
The ocular surface is comprised of the cornea, conjunctiva, eyelids and associated glands that are responsible
for secretion of the tear film. Dysgenesis or disruption of the homeostasis of any of these structures can lead to
corneal and ocular surface diseases, which can result in loss of eyesight or cause blindness. Understanding the
genesis of the ocular surface tissues, and its normal function and repair after disease or trauma, is crucial for
identifying disease-associated genes and novel drugs that may lead to innovative therapies that are essential
for maintaining visual health. We request support for the Gordon Research Conference and Seminar of the
Cornea and Ocular Surface Biology, Pathology and Regeneration (GRC-COSBPR), February 16-21, 2025, at
Four Points Sheraton-Holiday Express in Ventura, California. The goal of the 2025 GRC-COSBPR is to bring
together international leaders in the field and provide a forum for the most recent, cutting-edge basic, translational
and clinical research focused on expediting translation of findings from bench to bedside. Building on the strong
track record from the past six meetings, we plan 9 scientific sessions on key paradigm shifting innovations in
ocular surface biology, pathology, and tissue repair. The session titles are: 1. Novel Approaches to Data
Acquisition and Analysis; 2. Cellular Interactions, the Extracellular Matrix, and Morphogenesis; 3. Genomics and
Gene Regulation; 4. Advances in Cornea and Ocular Surface Wound Repair; 5. Mechanisms of Ocular Surface
Disease and Disorders; 6. Stem cells of the Ocular Surface; 7. Inflammation and Regeneration of the Ocular
Surface; 8. Sickness and Health of the Cornea and Ocular Surface; 9. Translation of Ocular Surface Research
into Novel Therapies. We are organizing a diverse, gender-balanced meeting with speakers invited from North
and Latin America, United Kingdom, Israel, Asia (Japan, India, China), and Australia. Special emphasis will be
given to increase diversity by inviting women and underrepresented minorities (URMs). Each session will be co-
moderated by an early career scientist paired with an established researcher. The sessions will include extended
time for discussions. A portion of each session is uncommitted to select speakers from submitted abstracts,
particularly graduate students, postdocs, clinician trainees, early career investigators, and URMs. The GRC
conference will include a “Power Hour” to discuss challenges women and underrepresented minorities face in
science and issues of diversity and inclusion. The 2025 GRC-COSBPR meeting will be advertised by the GRC
and the program updates will be posted on the website and via social media such as X (Twitter) and Facebook
to increase visibility among junior scientists and trainees. We believe our program is aligned with the scientific
goals of NEI and its support will enable us to provide a high quality and successful meeting.

Public health relevance
Project Narrative The proposal requests funds to support a meeting that brings together international leaders and early career investigators in cornea and ocular surface research. The meeting will provide a forum for the most cutting-edge basic, translational and clinical research aimed at developing novel therapies to prevent or treat corneal blindness.